Implementing lifestyle change interventions to improve health outcomes

Background: Diabetes and obesity collectively impact nearly half of American adults, costing hundreds of
billions of dollars per year and contributing to more than 1 in 5 U.S. deaths. Lifestyle change interventions
(LCIs) can mitigate the impacts of diabetes, obesity, and other cardiometabolic diseases but have been poorly
implemented, despite guidelines supporting their use and data supporting their efficacy and cost-effectiveness.
As both a Collaborating Center (Component A) and the LCI Research Network (LCIRN) Coordinating Center
(Component B), our team will facilitate collaboration, communication, translation, and dissemination of
research activities across LCIRN recipients and their partners through activities organized around eight key
activities. We are uniquely positioned for this dual role, offering infrastructure, shared methods, and pragmatic
tools to apply implementation science to solve intractable public health problems. LCIRN priorities include
understanding patient and provider decision-making around LCIs in the context of newer medications to treat
diabetes and obesity (i.e., Glucagon-like peptide-1 alone or in combination with gastric inhibitory polypeptide
receptor agonists; GLP1/GIP medications). These medications have revolutionized practice but work best
when combined with LCIs, making it critical to understand how to engage patients in LCIs in the context of
these increasingly prescribed medications. Aims: 1) Understand the factors that influence healthcare clinician
decision-making related to whether to refer patients to an LCI when prescribing GLP1/GIP medications; and 2)
Understand the factors that influence patient self-efficacy, motivation, and decision-making related to enrolling
in LCIs when being prescribed GLP1/GIP medications. Methods: To accomplish these goals, we will conduct
clinician and patient surveys and interviews to understand how to increase LCI referral by clinicians and
adoption by patients. Clinicians (n=500) across the US who refer to LCIs will be surveyed about factors
associated with referral (based on the Consolidated Framework for Implementation Research), outcomes
aligned with the RE-AIM outcomes framework, and implementation strategy (following the Evidence-based
Recommendations for Implementing Change taxonomy). Interviews with 32 clinicians will further elucidate
these responses. Surveys (n=1000) of and follow-up interviews (n=32) with adults taking GLP1/GIP
medications will aim to understand how self-efficacy, motivation, and other factors impact willingness to adopt
LCIs. Analysis of these data will apply precision implementation methods to identify data-driven, efficient
strategies to increase LCI implementation and adoption. Outcomes/Impact: This research will result in data-
driven plans to increase LCI implementation for individuals who are prescribed GLP1/GIP medications
(Component A), while our coordinating center will ensure that these findings and other findings across the
network are effectively translated to ultimately increase the adoption, implementation, and sustainability of LCIs
among and for people with obesity and diabetes. (Component B).

Public health relevance
We propose an innovative research initiative and coordinating center designed to accelerate the real-world impact of evidence-based public health interventions for weight loss and dietary improvement in individuals with diabetes and obesity. By leveraging cutting-edge implementation science methods, we will bridge the gap between research and practice—ensuring that proven lifestyle change interventions reach the people who need them most.